Mechanisms and Functions of Iron-Sulfur Helicase in DNA Repair

PROJECT SUMMARY
DNA replication is frequently blocked by DNA damage or other obstacles (e.g. transcription complexes) that
must be overcome to allow replication to continue. Specialized pathways are essential for rescuing stalled DNA
replication forks to allow replication to proceed. Our collaborators in the Lovett laboratory use 3’-azido-
3’deoxythymidine (AZT) as a reagent to block DNA replication in Escherichia coli, and they identified two
genes, yoaA and holC, that work together to give cells tolerance to AZT. Protein sequence predicts, and our
biochemical results confirm, that the first gene, yoaA, encodes an iron-sulfur (Fe-S)-containing DNA helicase in
the Rad3/XPD family. The second gene, holC, encodes the c subunit of the DNA polymerase III holoenzyme
and we have uncovered a novel function for c as a subunit of the YoaA helicase. DNA helicases, including the
Rad3/XPD family of Fe-S-containing DNA helicases, play essential roles in maintaining genome stability by
participating in DNA repair and rescuing stalled replication forks. There are four Rad3/XPD family members in
humans, XPD, FANCJ (a.k.a. BRIP1), DDX11 (a.k.a. ChlR1), and RTEL1, that are crucially important for
human health. Genetic disorders linked to mutations in these helicases are typically associated with genome
instability, a predisposition to cancer, and a number of other pathologies. Our parent proposal defines
biochemical and molecular mechanisms for the newly discovered E. coli family member, YoaA. The main
premise is that YoaA and c constitute a DNA helicase that is involved in the repair of damaged 3’ ends at
stalled replication forks. Our aims are to: 1) characterize the YoaA•c protein, 2) characterize the helicase
activities and substrate preferences for YoaA•c, and 3) determine how c contributes to YoaA activities in vitro,
and to develop a cy fusion protein for assaying functions of c as a subunit of YoaA versus the DNA
polymerase III holoenzyme in vivo. Our parent proposal will provide the first biochemical characterization of the
YoaA•c helicase, a member of the Rad3/XPD family of helicases which play critical roles in human health by
maintaining genome stability. This equipment supplement requests the purchase of a LUMICKS M-trap
optical tweezer system with wide-field fluorescence to measure helicase activities of YoaA•c (and
YoaA) at the single-molecule level. This purchase will directly support the experiments in Aims 2 and 3 of
our parent proposal investigating the mechanism of YoaA and contributions that c makes to the helicase
activities of YoaA. To date, XPD is the only Rad3/XPD family member that has been characterized using this
type of single-molecule methodology. Identifying similarities and differences in the activities of these family
members is important for understanding their functions under normal conditions and dysfunction in disease
states. Moreover, this single-molecule approach is highly complementary to the ensemble experiments that we
are currently doing and together will provide a more comprehensive view of the YoaA-c helicase than either
approach alone would give, thus strengthening the impact of our project.

Public health relevance
PROJECT NARRATIVE We propose to purchase a LUMICKS M-trap optical tweezer system with wide-field fluorescence to investigate the mechanism of the YoaA-c (and YoaA) helicase at the single-molecule level. Rad3/XPD-family DNA helicases such as YoaA play a crucial role in human health by helping to maintain genome stability. The single- molecule approach is highly complementary to the ensemble experiments that we are currently doing to define the mechanism of the YoaA helicase and will increase the impact of our project.